Critical roles of RNA m5C-MBD6-H2AK119ub deubiquitylation axis in TET2-mediated HSC regulation

Abstract
TET2 is commonly mutated in adult myeloid malignancies and normal individuals with clonal hematopoiesis.
TET2 plays an important role in the regulation of hematopoietic stem/progenitor cells (HSCs/HPCs; HSPCs) as
TET2 loss leads to hallmark HSC self-renewal enhancement with skewed differentiation towards monocytic
lineage. Besides DNA 5-methylcytosine (5mC), TET2 also catalyzes RNA 5-methylcytosine (m5C) oxidation. The
catalytic activity of TET2 is required for normal HSPC function, we therefore speculate that the enzymatic activity
of TET2 on RNA also contributes to HSPC regulation. Indeed, TET2 can control chromatin state and transcription
by binding to an RNA-binding protein PSPC1 and modulating RNA m5C oxidization in mouse embryonic stem
cells (mESCs). Stimulated by a recent study discovering a novel mechanism of chromatin regulation through
reversible N6-methyladenosine modification on chromatin-associated RNA (caRNA), we explored the potential
chromatin regulation through the TET2-mediated caRNA m5C oxidation, which led to the following exciting
findings: (i) TET2 oxidizes m5C on caRNAs to hm5C (5-hydroxymethylation ) with long terminal repeat (LTR)
RNAs as the main substrates. (ii) MBD6 is a specific RNA m5C reader protein and NSUN2 is a main m5C writer
protein for caRNAs. (iii) MBD6, via binding to m5C-modified LTR RNAs, recruits H2AK119ub deubiquitylase
complex to mediate local chromatin activation in mESCs. Based on these findings, we hypothesize that TET2
exerts its regulatory function in HSPCs mainly through caRNA m5C oxidation, and deregulation of caRNA m5C-
MBD6-H2AK119ub deubiquitylation axis upon TET2 loss/mutation leads to altered HSPC gene expression and
function. To test our hypothesis, we will: (1) Define the importance of TET2-mediated caRNA m5C oxidation in
the regulation of HSPC function. We will first identify in HSPCs the key caRNAs with altered m5C methylation
upon TET2 loss and corelate with local gene expression. We will then examine the impact of caRNA m5C
deregulation on TET2 deficiency-mediated abnormal HSPC function and gene expression by using Nsun2
knockout (normalize the caRNA m5C increases upon TET2-loss) as well as targeted demethylation (with
dCas13Rx-TET2CD) and methylation blockage (with steric anti-sense oligo) of individual TET2 LTR RNA target.
(2) Investigate the significance of RNA m5C reader, MBD6, in TET2-mediated regulation of HSPC by examining
the impact of MBD6 loss on TET2 deficiency-mediated hallmark abnormal HSPC function and gene expression.
3) Validate the roles of caRNA m5C-MBD6-H2AK119ub deubiquitylation axis in human HSPCs. We will also
investigate whether mutations of TET2 impair caRNA m5C-MBD6-H2AK119ub deubiquitylation axis in HSPCs
from TET2-mutated myeloid malignancies. The sensitivity of TET2-mutated vs. TET2-WT HSPCs to MBD6 or
NSUN2 loss will also be accessed. Success of the proposed studies will gain fundamental knowledge on HSPC
biology by establishing caRNA m5C-MBD6-H2AK119ub deubiquitylation axis as a critical and novel pathway for
TET2-mediated HSPC regulation. These studies can lead to novel strategies to target TET2-mutated HSPCs.

Public health relevance
Narrative This application aims to establish caRNA m5C-MBD6-H2AK119ub deubiquitylation axis as a critical and novel pathway for TET2-mediated HSPC regulation. The proposed studies will gain fundamental knowledge on HSPC biology and lead to novel strategies to target TET2-mutated HSPCs.